Mindfulness-based Neurofeedback to augment DBT psychotherapy for adults with Borderline Personality Disorder (MIND-BPD)

Project Summary
The proposed project is a clinical trial of a mindfulness-based neurofeedback (mbNF) intervention used to
augment Dialectical Behavior Therapy (DBT) skills group training in adults with borderline personality disorder
(BPD). DBT is the best-evidenced treatment for BPD. Its full implementation involves up to 20 hours per week
of clinical contact for 6-12 months. Recent studies have shown that weekly brief DBT skills groups (DBTsg)
also provide clinical benefit for people with BPD. Here, we propose to amplify DBTsg training with mbNF.
Mindfulness is a foundational skill for DBT that is emphasized throughout each DBT module. Our aim is to
strengthen the ability of subjects to practice mindfulness effectively, and thereby to amplify the therapeutic
benefits of DBTsg. In our study, people with BPD will enroll, participate in a real-time fMRI mbNF intervention,
and subsequently participate in DBT. The mbNF intervention involves engaging in mindfulness meditation
while receiving feedback on how well one's brain patterns reflect a focused mindful state in which the fronto-
parietal control network (FPCN: controls cognitive focus) has high activity while the default mode network
(DMN: associated with less mindful brain state) has low activity. We hypothesize that mbNF will strengthen the
brain circuitry supporting mindfulness and thereby amplify the clinical benefits obtained in the DBTsg. Our past
studies using mbNF have demonstrated that it decreases hyperconnectivity within the DMN, increases
anticorrelations between the DMN and FPCN, increases connectivity between frontal control regions and
amygdala, improves measures of state mindfulness, and yields clinical benefits in neuropsychiatric
populations.
The proposed study adopts a randomized, double-blind trial design to examine whether mbNF in patients
with BPD induces the expected changes in DMN connectivity (decreased internal connectivity and increased
anticorrelations to FPCN). We will also test whether mbNF amplifies clinical efficacy of DBT. Efficacy on both
brain and clinical measures will be determined via comparison to a control group that receives yoked sham
feedback and DBT. Importantly, the persistence of training effects will be monitored over several months.
Neurofeedback naturally supports a closed loop intervention development cycle in which neuroscientific
and clinical knowledge develop together. The proposed study would leverage this approach in the
development of novel therapeutic options for BPD. It will inform our understanding of the neural substrates
supporting clinical efficacy of DBT in BPD and could lead to development of the first neuroscience-based
treatment option for patients with BPD.

Public health relevance
Project Narrative Borderline Personality Disorder (BPD) is a common and disabling psychiatric disorder; gold standard treatments leave many patients with ongoing symptoms and profound socio-occupational deficits. Mindfulness training is at the core of one of the best-evidenced BPD treatments, Dialectical Behavior Therapy (DBT), and mediates some of the therapeutic change seen with treatment. Accordingly, the proposed research will investigate whether an innovative mindfulness-based real-time fMRI neurofeedback intervention elicits change in the brain circuits associated with mindfulness to improve clinical outcomes in adults with BPD undergoing DBT.